STUDIES OF ORGAN TRANSPLANTATION IN ANIMALS AND MAN

This is an application for continuation of a program project grant. The basic overall objectives have been to: (a) Analyze and isolate the clinical problems involved in organ transplantation and precisely document clinical-laboratory correlations. (b) Organize clinical trials based on available data to solve clinical problems. (c) Generate experimental solutions to these problems which can ultimately be applied to the clinical problem. Within these objectives, there are four essential aims in clinical transplantation under which all our projects have been organized. Aim 1: To Prevent Organ Destruction by host. This includes problems of tissue typing, matching, and immunosuppression related to rejection as well as problems of recurrent disease. Aim 2: To Counteract Infection. Aim 3: To Maximize Rehabilitation. Aim 4: To Maintain Patient and Organ in Optimal Condition Prior to and During Transplantation. This includes problems of hemodialysis, organ retrieval, and storage.